CORE 2 - Mass Spectrometry Core

PROJECT SUMMARY/ABSTRACT – Core 2-Lipid Mass Spectrometry Core
The Lipid Mass Spectrometry Core (LMSC) will draw on the strong lipid mass spectrometry culture at UT
Southwestern in the Center for Human Nutrition that has been developed and is managed by Dr. Jeff McDonald
to serve needs of UT Southwestern NORC investigators. Through an extensive suite of instruments in the Center
along with significant experience and knowledge in all aspects of mass spectrometry-based lipid analysis, the
goal of this Core is to support all NORC investigators to provide lipid measurements needed relevant to their
NORC research projects. The three primary objectives of the LMSC are: 1) Provide quantitative analysis of
targeted lipid classes that include fatty acids, sterols/oxysterols, bile acids, steroids, eicosanoids, and
sphingolipids; 2) Provide untargeted, relative lipidomic analysis that covers the major classes of lipids including
steryl esters, glycerolipids, phospholipids, and sphingolipids; and 3) Develop novel methods to support unique
needs of NORC investigators. The services and capabilities provided by the LMSC cover almost all aspects of
lipid analysis from extraction to analysis to data interpretation and dissemination. The LMSC has proven
capabilities from effectively handling large cohorts (clinical and research) for targeted lipid analysis to broad
exploratory work on small pilot projects.